2025 APSA South Regional Conference Meeting the Needs: Fostering a Future with Diverse Physician Scientists

ABSTRACT
Since the 1950s, integrated dual-degree MD/PhD training programs have enabled individuals with a passion for
both science and medicine to pursue unique and impactful careers as physician scientists. These training
programs empower individuals to play pivotal roles translating cutting-edge research into clinical applications
that improve patient care by honing scientific rigor and transferrable skills and preparing students to become
leaders in the biomedical research workforce. However, the number of physician scientist trainees has remained
stagnant for more than a decade, challenging the objective to recruit and retain a large and diverse population
of biomedical research leaders capable of addressing the nation’s evolving health care needs. Collaborative
efforts by the National Institutes of Health, the Association of American Medical Colleges, and the National
Association of MD-PhD Programs strive to increase support and foster the needs of aspiring physician scientists.
More recently, the American Physician Scientists Association (APSA), a student-led national organization “by
trainees, for trainees” has committed to addressing these obstacles by providing career development
opportunities and serving as a voice for students of dual-degree training programs at all levels. To cultivate
regional communities of physician scientist trainees, APSA empowers students in MD/PhD programs to organize
and host regional meetings across the United States, spanning five regions: West, South, Midwest, Mid-Atlantic,
and Northeast. The 2025 APSA South Regional Conference, hosted by the Baylor College of Medicine (BCM)
Medical Scientist Training Program, aims to inspire and support early-career trainees from diverse backgrounds
as they embark on the physician scientist career pathway. This one-day conference will feature scientific and
career development sessions led by established physician scientists, panel discussions featuring regional
academic leaders, oral and poster presentations by current MD/PhD trainees, and interactive educational
workshops tailored to meet the specific needs of students at various stages of training. Focused outreach efforts
will engage students from diverse backgrounds including those underrepresented in medicine and students with
disabilities. By providing a platform for inter-institutional collaboration, longitudinal mentorship, and career
development, the 2025 APSA South Region Conference will cultivate an inclusive community of physician
scientists with an emphasis on the importance of diversity in the biomedical workforce.

Public health relevance
PROJECT NARRATIVE Physician scientists play vital roles translating scientific discoveries into improved patient care; thus, it is essential to have a diverse workforce with robust mentorship networks to address the unique health needs of the nation’s communities. The 2025 APSA South Regional Conference: Meeting the Needs aims to inspire and support both current MD/PhD trainees across the Southern US and future trainees from diverse backgrounds to pursue careers as physician scientists through educational workshops, mentorship opportunities, and scientific networking. By bringing together professionals and trainees in a range of career stages, this conference will create a supportive community and provide resources to overcome systemic barriers and strengthen the physician scientist workforce.